Posterior Hypothalamic Contribution to Stress Adaptation

Project Summary
The overall aim of this project is to determine the contribution of the rostral region of the posterior hypothalamic
nucleus (rPH) in stress adaptation. More specifically, stress habituation is defined as a progressive reduction in
responses upon repeated exposures to the same (homotypic) stressor. Psychological or “emotional” stressors
elicit a range of behavioral, autonomic, and neuroendocrine responses that normally help organisms cope with
perceived or actual threatening situations. However, prolonged, unabated and chronic stress exposure is
frequently associated with the development, precipitation, or exacerbation of several psychopathologies and
physical disorders. The sustained activation of stress responsive systems can negatively affect physiologic
functions and ultimately, survival. Thus, the reduction or inhibition of stress-elicited responses afforded by
habituation is likely a vital mechanism serving to reduce the cumulative impact of the same stressors experienced
repeatedly. Importantly, impaired habituation has been reported in several human clinical populations including
anxiety and mood disorders. Unfortunately, the neural mechanisms responsible for stress habituation are still ill-
defined, which makes it currently impossible to evaluate the contribution of habituation in psychopathologies.
In this application, robust habituated neuroendocrine, autonomic and behavioral responses will be obtained
to repeated homotypic stress paradigms that will test the response specificity and generality of the proposed
brain manipulations. Based on detailed anatomical and functional results from our laboratory, emphasis will be
placed on the role of the rPH in the acquisition of stress habituation. Anatomically, the rPH is located at a focal
intersection between several sensory, limbic forebrain, and effector response systems activated by various
stressors, placing it in a unique position to undergo habituation-related plasticity that can regulate coordinated
responses to stress. The first aim is therefore directed at evaluating the novel hypothesis that the rPH region,
and some of its specific cell populations, contribute to the acquisition of stress habituation. Aim 2 seeks to
evaluate the possibility that intrinsic rPH neural activity is modified by repeated homotypic stress. Throughout
these aims, both female and male rats will be evaluated for putative rPH-related differences in stress adaptation
due to the differential prevalence of gender to anxiety and mood disorders and the widely reported sex
differences in habituation to stress. The proposed anatomical, functional and behavioral analyses of the rPH in
stress adaptation through habituation is novel and will provide converging evidence implicating this brain region
in stress adaptation and its sequelae.

Public health relevance
Project Narrative Whereas innate responses to stress provide many important physiological mechanisms to help cope with the demands of daily challenges, the prolonged or repeated exposure to stress is associated with several psychopathologies and physical disorders. The current application seeks new information about a brain region, the rostral region of the posterior hypothalamic nucleus, that is centrally situated to integrate multiple sources of information, coordinate multiple stress-related responses, and that may significantly contribute to reduce the impact of repeated stress. This novel hypothesis could provide a breakthrough in the understanding of this normal, but ill-defined, stress adaptive process, which could suggest new avenues for the treatment of mood and anxiety disorders.